Determining how Sox9 taste progenitors are established embryonically and contribute adult taste buds

Project Summary
Hundreds of taste buds (TBs) are located in the epithelial trenches of the circumvallate taste papilla (CVP) at
the posterior midline of the tongue. Each TB contains taste receptor cells (TRCs) that transduce taste
information to the brain and are continually replaced from stem/progenitor cells outside of TBs. Cancer patients
undergoing chemo- or radiotherapy often experience dysgeusia, or taste dysfunction, likely due to perturbation
to TRC renewal. Patients experiencing dysgeusia have increased risk of depression, malnutrition, and poor
treatment outcomes. Therefore, understanding the mechanisms regulating maintenance of taste epithelium
and TRC renewal will inform development of treatments to prevent or restore taste loss in these patients.
CVP homeostasis occurs through proliferation and differentiation of progenitor cells that generate both TRCs
and the surrounding non-taste epithelium. Our lab has recently identified new, long-term SOX9+ progenitors
that, as a population, generate TRCs and non-taste epithelium (NTE); however, the potential of individual
SOX9+ progenitors is unexplored. SOX9+ progenitors are located distant from taste buds, in the epithelial
junction linking CVP trenches to the ducts of the underlying von Ebner's minor salivary glands (VEG). Each
CVP contains a dozen or more junctions containing SOX9+ cells, suggesting that multiple independent
progenitor reservoirs contribute to taste epithelium. Additionally, in contrast to the highly proliferative CVP, the
junction contains few proliferative cells, indicating SOX9+ cells are slow cycling. These findings lead to my
hypothesis that individual SOX9+ progenitors from multiple junctions produce progeny that move into
local CVP trench epithelium, become highly proliferative, and differentiate into TRCs and NTE. Thus, in
Aim 1, I will use sparse SOX9 lineage trace, whole-tissue clearing, and EdU birth dating, to determine the
lineage and proliferative potential of individual progenitors from multiple junctions.
Our previous work has focused on SOX9+ progenitor contribution in adult homeostasis, but if and when these
taste stem cells are established embryonically is unknown. Embryonic immunostaining reveals SOX9+ cells are
present during initial formation of the CVP and have overlapping expression with Ptch, the Shh signaling
receptor. Shh is necessary for anterior tongue taste bud development, and proper CVP trench invagination in
the posterior tongue. These findings lead to my second hypothesis that embryonic Shh signaling is required
to establish adult SOX9+ taste progenitors. In Aim 2, I will use embryonic lineage tracing and genetic
deletion of Shh signaling in SOX9+ cells to determine when SOX9+ cells are established, begin contributing to
TBs, and if Shh signaling is required in these processes. Overall, this work may lead to approaches to leverage
concentrated pools of taste stem cells to restore taste function in patients.

Public health relevance
Project Narrative Cancer patients undergoing chemo- or radiotherapy often experience alteration or loss of taste function, which can impact their quality of life and prognosis outcomes. Therefore, understanding how taste is maintained under homeostasis provides a critical foundation for the development of therapies to treat taste dysfunction. The circumvallate papilla is an ideal model to study this, as it comprises hundreds of taste buds; this proposal seeks to understand CVP homeostasis by understanding when taste stems arise during development and how they contribute to taste buds in adults.